Pathways to Prevention: Exploring Social Determinants of Health in Early Onset Colorectal Cancer

PROJECT ABSTRACT
Background: Early-onset colorectal cancer (EOCRC), defined as colorectal cancer (CRC) diagnosed before age 50,
has been on the rise in the United States, with age-adjusted incidence increasing from 5.9 cases per 100,000
individuals in 2000 to 8.4 cases in 2017, and mortality rising by approximately 1.3% annually from 2008 to 2017.
Factors contributing to EOCRC include lifestyle factors, chronic diseases, family history, and multi-level social
determinants of health (SDoH), which encompass conditions such as economic stability, education access and quality,
healthcare access and quality, neighborhood and built environment, and social and community context. Notably,
Black/African American people and individuals in rural communities face greater SDoH burdens and significant
inequities in EOCRC outcomes. Our preliminary research shows that EOCRC mortality hotspots are more prevalent in
southern U.S. counties with higher proportions of Black residents. However, lack of research including integration of
comprehensive and multifaceted SDoH factors into evaluation of EOCRC disparities. Objective/Hypothesis: The
primary objective of this study is to evaluate the impact of various SDoH on EOCRC diagnosis and delays in the first
course of treatment and survival, focusing on geographically and racially underserved populations in Kentucky and
Georgia. We hypothesize that SDoH measures related to economic stability, education, healthcare access,
neighborhood environment, and social context significantly influence EOCRC outcomes, with a greater impact on
younger populations (under 50 years). Specific Aims: The study will utilize an epidemiologic approach analyzing
secondary data within two specific aims. Aim 1: To elucidate the relationship between standardized measures of
SDoH and CRC diagnosis, and whether these associations are modified by age at diagnosis, sex, and race/ethnicity.
We will analyze cohort data from the All of Us research program (Nov 2021-2024) to examine the association between
SDoH and CRC diagnosis, stratified by different ages at diagnosis (<50 and ≥50 years; <45 and ≥45 years), sex, and
race/ethnicity. Aim 2: To examine the relationship between area-level SDoH and delays in treatment and survival for
CRC in Georgia and Kentucky, and whether these associations are modified by age at diagnosis. We will use
retrospective cohort data from the 2014-2024 Kentucky and Georgia cancer registries. Cox proportional hazards
models will assess the association between area-level SDoH (defined by the social vulnerability index [SVI]) and
delays in the first course of treatment (time between diagnosis and treatment start) and survival, stratified by age at
diagnosis (<50 and ≥50 years; <45 and ≥45 years). Cancer Relevance: This research addresses critical gaps in
understanding how various SDoH impact EOCRC outcomes among younger populations in underserved
communities. Findings will inform public health initiatives and policies to improve equitable access to cancer diagnosis
and treatment resources for young adults in Kentucky and Georgia, ultimately contributing to EOCRC mortality
reduction and better health outcomes in these populations/communities.

Public health relevance
PROJECT NARRATIVE Early-onset colorectal cancer (EOCRC) has been rising in incidence and mortality in the United States, with significant disparities observed among Black/African American individuals and those in rural communities, highlighting a critical research gap in understanding the impact of social determinants of health (SDoH) on these outcomes. The goal of this study is to understand the specific individual-level and area-level SDoH factors that contribute to CRC diagnosis, delays in first course of treatment for CRC, and CRC-specific survival disparities, and whether these associations are modified by age at diagnosis. Ultimately, these findings will inform targeted public health interventions and policies to improve health outcomes and reduce mortality associated with EOCRC in underserved populations/communities.